Engineered hybrid aging model for disease progression

Project Summary
Aging is a risk factor for many diseases such as cancer, cardiovascular diseases and neurodegenerative
diseases, with the incidence of such diseases peaking between ages 60 and 80. Although both the cellular
and the extracellular components of a tissue change with age, current preclinical models have focused on
the aging-related changes in cells and overlooked the alterations in the microenvironment, specifically the
extracellular matrix (ECM), which is one of the main reasons for the low success rate of pre-clinical to
clinical translation. Thus, it is imperative to create disease models that mimic the aging microenvironment
to better study disease initiation and progression, as well as reliably test for drug efficacy. Here, as a
proof-of-concept aging-associated disease, for the first time in literature, we propose to engineer
decellularized aged human ECM (dECM)-based 3D tumor models and implant them into immunodeficient
mice to create hybrid mouse models to study the effect of matrix age on tumor progression and drug
response. We will follow a bottom-up approach to establish the hybrid mouse model; first we will engineer
the aging stroma using aged human breast dECM and aged human stromal cells both derived from
healthy donors, then grow aged patient-derived tumor organoids on the stroma to engineer the 3D in vitro
tumor models, and finally implant the 3D tumors into immunodeficient mice to create the hybrid mouse
models. Hence, we aim to establish reliable and human representative preclinical models, 3D tumor
models and hybrid mouse models, which allow us to distinguish the individual and combined effect of
aging components (i.e. ECM, stromal cells, and tumor cells) on tumor initiation and progression. We will
then mechanistically test the individual effects of aged ECM characteristics, such as the altered stiffness,
fiber structure and biochemical composition on tumor progression. The proposed work aims at solving
many problems of the current preclinical models. First, we will produce in vitro and in vivo preclinical
models that consider the effect of aging human ECM on cancer progression. Second, by creating hybrid
models, we will address the lack of systemic response in the 3D models, and the lack of control and
inability to discern the effects of individual components in in vivo models. Finally, we will create tumors in
mice that better represent the human response and benchmark our hybrid model with actual patient
samples.
To achieve these goals, we will combine our expertise in tissue engineering, mouse model systems,
transcriptomics, primary cell culture model systems, and breast cancer research. Once fully implemented
and functionally validated, we expect our state-of-the-art tissue engineered 3D disease models as well as
the hybrid mouse models to serve as the next-generation research platform for both basic and
translational cancer research and high-throughput drug discovery.

Public health relevance
The goal of this study is to design and develop a fully characterized novel tissue engineered disease model of aged tissue environment integrated with a mouse model as a system to study the role of aging in disease initiation and progression. With a fully integrative approach implementing human tissue analysis, state-of-art tissue engineering approaches and by incorporating the engineered tissues in a hybrid mouse model for physiological relevance, we propose a highly interdisciplinary project to reconstruct and validate aged human tissue at the molecular, cellular and physiological levels. The tissue engineered 3D models as well as the hybrid mouse models developed here will be of great importance in isolating the effects of aged human (i) ECM, (ii) stromal cells, and (iii) disease cells on disease progression.